Immune Dysfunction in HIV + Opiod Users

Abstract
Miami is at the epicenter of the US HIV/AIDS epidemic, leading U.S. cities in HIV incidence with the highest HIV
infection case rate (51.2 per 100,000). Concurrently, dependence on or addiction to opioids is widely prevalent,
more so in the HIV+ population that is vulnerable for multiple reasons including need for pain medications. The
University of Miami is actively pursuing projects to curb HIV and opioid epidemics. We are currently conducting
a study to investigate the impact of opioids on immune responses in PWH and PWoH as compared to non-
opioid users with and without HIV. The premise for the primary grant (R01DA051202) was that HIV infection
and opioids are independently harmful for the immune system. HIV impairs immunity that is associated with
persisting immune activation even after durable virologic control, while opioids (OP) are immunosuppressive.
Together, they can potentially compound the damage to the immune system, leading us to hypothesize that
people with HIV (PWH) who abuse opioids are likely to damage their immune system which would grossly blunt
the immune response to influenza vaccine. We enrolled 4 study groups on the basis of HIV status and chronic
opioid use: HIV+OP+, HIV+OP-, HIV-OP+, HIV-OP- using stringent enrollment criteria to evaluate flu vaccine
induced Ab responses as well as B/T cell interaction by study of peripheral T follicular helper cells (Tfh), the
memory CD4 T cells that are intimately involved in stimulating B cells to produce Ab to vaccine antigens. We
found that the HIV+OP+ group exhibited high level of inflammation and immune activation (IA). We used
rigorous statistical tools, and determined that Opioids were the major drivers of inflammation while HIV was the
main driver of cellular immune activation of T cells. Unexpectedly, we found that people with OUD had better
Ab responses based on titer and fold increase from baseline than non-opioid using population, and the same
was true for HIV+OP+ group in comparison to HIV+OP- group, which had the lowest Ab responses as expected.
Age in the study population as a whole was inversely correlated with Ab responses, but we do not have sufficient
numbers of aged people with OUD in our cohort to assess if age was influencing the immune response or
whether OP also circumvent the deleterious effects of HIV or Aging on Flu vaccine response. In this supplement,
we plan to enroll additional “old” OUD participants to assess the impact of age on the immune response and
understand whether OP use can circumvent the deleterious effects of Aging or of HIV on Flu vaccine responses.
We will investigate if underlying mechanisms involve a unique inflammatory cytokine pattern or signaling
pathways in monocytes that affect their cytokine output. We also plan to examine the nature of the Flu Ab
secreted to assess whether the secreted Ab has functional diversity.

Public health relevance
Narrative Many people with chronic pain use opioids for relief and can develop an Opioid Use Disorder (OUD) and in some cases, become dependent on injection drug use. We have investigated immune responses to flu vaccine and noted that despite OUD and HIV, the vaccine responses were better than expected as compared to people not engaged in Opioid use. As age is a negative factor in vaccine responses, in this supplement we are examining the impact of age and OUD in people with and without HIV in relation to Flu vaccine responses.